University of Michigan BACPAC Mechanistic Research Center

PROJECT SUMMARY / ABSTRACT
OVERALL COMPONENT
The NIH BACPAC initiative is designed to “generate new knowledge regarding phenotypes, endotypes,
mechanisms, diagnostics, trial outcomes, and therapeutic responsiveness . . . in chronic low back pain (cLBP).
We feel that our group at the University of Michigan (UM) is ideally suited to lead a Mechanistic Research
Center (MRC) as part of the broader BACPAC initiative, because we have been working along all of these lines
for over twenty years. We propose a single Research Project that will take patients with cLBP and use a
patient-centric, SMART design study to follow these individuals longitudinally as they try several different
evidence-based therapies, while mechanistic studies are overlaid to draw crucial inferences about what
treatments will work in what patient endotypes. We use the term Interventional Response Phenotyping to
describe the need in any precision medicine initiative to phenotype participants regarding what therapies they
do and do not respond to - so that one can later link mechanistically distinct disease endophenotypes with
those who preferentially respond to therapies targeting those mechanisms. The first Specific Aim of the UM
BACPAC MRC is to perform Interventional Response Phenotyping in a cohort of cLBP patients (n=500). We
will perform a long-term pragmatic trial using a well-established cohort of cLBP patients, who will receive a
sequence of interventions known to be effective in cLBP. All cLBP participants will for the first 6 weeks receive
a web-based patient self-management program for pain. This first treatment period is not testing mechanistic
hypotheses, but instead will reduce or eliminate regression to the mean, as well as the placebo effect of
interacting with staff, prior to subsequent randomized treatments. Then participants who remain symptomatic
will be enrolled in an adaptive, Sequential Multiple Assessment Randomized Trial (SMART) to randomize
individuals to two additional treatments given for 12 weeks each, from a list including: a) mindfulness-based
cognitive therapy (MBCT); b) physical therapy and exercise; c) duloxetine, d) gabapentin and e) self-
administered acupressure. At any point during the study, participants (as part of ongoing care) may also
undergo an epidural steroid or facet joint injection, or lumbar surgery. Although participants will not be
randomized to receive these interventional therapies, we can assess for predictors of differential
responsiveness. The second Specific Aim of this proposal is to demonstrate that currently available, clinically-
derived measures, can predict differential responsiveness to the above therapies (n=500). The third Specific
Aim is to identify new experimental measures (functional neuroimaging, quantitative sensory testing, plasma
measures of inflammation, autonomic tone) that predict differential responsiveness to the each of the
therapies, as well as to infer mechanisms of action of treatments (n=200). The fourth Specific Aim is to
contribute to the broader BACPAC initiative by providing data on our MRC participants, as well as contributing
scientific expertise, research methods, and leadership to BACPAC.

Public health relevance
PROJECT NARRATIVE OVERALL COMPONENT Relevance statement. An estimated 42 million American suffer from chronic low back pain. Current treatments are only modestly effective and this is likely due to our inability to know which patients will respond to what treatments. As part of the BACPAC initiative our mechanistic research center aims to be a team member in realizing the vision of personalized medicine for individuals with cLBP.